The Role of Ischemia Reperfusion Injury in Lung Allograft Rejection

Abstract
The success of lung transplantation is limited by ischemia reperfusion injury-mediated primary
graft dysfunction and allograft rejection, two processes that we have shown are immunologically
linked. Current strategies to reduce graft rejection and improve survival are mostly based on
targeting adaptive immune cell populations in the recipient. These approaches are only modestly
effective and carry high risks of life-threatening infections and development of malignancies. We
have shown that neutrophilic graft infiltration during ischemia reperfusion injury is a major driver
major driver of alloreactivity. Therefore, a complementary approach to prevent rejection is to
target innate immune pathways that are activated during ischemia and reperfusion. The ability to
dampen the initial immune response following lung transplantation represents a promising avenue
to increase allograft tolerance and improve clinical outcomes. Our recent work has identified that
necroptosis, a non-apoptotic form of inflammatory cell death mediates the early inflammatory
response after reperfusion of pulmonary grafts. Recent work has suggested that the removal of
apoptotic neutrophils by macrophages, a process referred to as efferocytosis, induces synthesis
of specialized pro-resolving mediators pointing to mechanistic targets to prevent ischemia
reperfusion injury. Also, we have generated new data that selectively inducing metabolic stress
in neutrophil apoptosis triggers innate immune responses that limit ischemia reperfusion injury.
We have additionally reported that treatment with Resolvin D1, an endogenous pro-resolving lipid
mediator, inhibits neutrophil recruitment, downregulates inflammatory pathways and reduces
ischemia reperfusion injury. In this proposal, we will use state-of-the-art techniques, including
intravital microscopy, single cell RNA sequencing, oxidative lipidomics, multi-omics imaging mass
spectrometry and novel mouse strains to perform studies that will 1) define mechanisms and
impact of cell death (Aim 1), 2) define mechanisms that contribute to the endogenous production
of specialized proresolving lipid mediators after lung transplantation (Aim 2) and 3) define
mechanisms of action and immunological impact of specialized pro-resolving mediators (Aim 3)
in driving innate inflammatory and alloimmune responses after lung transplantation. Our studies
will lay the foundation for novel therapy that will improve outcomes after pulmonary
transplantation.

Public health relevance
PROJECT NARRATIVE Lung transplantation is an established therapy for many patients who suffer from end stage pulmonary failure. Current treatment strategies for lung transplant recipients, which rely on targeting adaptive immune cells in the recipient, have many side effects and are only modestly effective as many lungs ultimately fail due to graft rejection. In this grant application we propose to study alternative approaches which are based on targeting innate immune pathways that are activated immediately after reperfusion of the transplanted lung and augment alloimmune responses.